NHLBI CARDIOTHORACIC SURGICAL BACK-UP COVERAGE

The NHLBI Division of Intramural research requires a contract in order to renew cardiothoracic back-up coverage for clinical center patients undergoing PCI treatment.